SALESFORCE LICENSES

NHLBI / OM / ITAC continues to use Salesforce licenses (DOCS and NXP applications) to provide to the global leadership for a research, training, and education program to promote the prevention and treatment of heart, lung, and blood diseases and enhance the health of all individuals. It creates and supports a robust, collaborative research infrastructure in partnership with private and public organizations, including academic institutions, industry, and other government agencies. The goal is to provide the NHLBI IOD and the OSPEEC correspondence management that engages and improves service to stakeholders and individuals more accurately and efficiently, reducing technology costs by utilizing a system built on Salesforce.